The Role of S1PR2 in MRSA-induced Barrier Dysfunction and Lung Injury

PROJECT SUMMARY/ABSTRACT
The acute respiratory distress syndrome (ARDS) is a life-threatening condition that occurs frequently in critically
ill patients. Sepsis and pneumonia are leading causes of ARDS, with methicillin-resistant Staphylococcus aureus
(MRSA), a gram-positive, antibiotic-resistant bacteria, being a significant contributor. MRSA infection causes
acute inflammatory injury to the lung (acute lung injury-ALI) that disrupts the vascular endothelial barrier leading
to alveolar edema, a hallmark pathophysiologic feature of ARDS. Thus, the development of vascular-targeted
therapeutic strategies aimed at restoring and preserving the lung endothelial barrier integrity is of critical
importance for the effective management of ARDS. Sphingosine-1-phosphate (S1P) is an endogenous bioactive
lipid that plays critical roles in regulating endothelial cell (EC) processes, including vascular barrier function. Lung
EC predominantly express the S1P receptors 1-3 (S1PR1-3), where S1PR1 has a well-established role in in
promoting barrier function, and S1PR3 is associated with barrier dysfunction. However, the role of S1PR2
remains much less well-defined. Our preliminary findings demonstrate that inhibition of S1PR2 exacerbates
MRSA-induced lung injury in vitro and in vivo. Notably, S1PR2-deficient mice exhibit significantly worse injury
compared to wild-type animals when infected with MRSA, while pharmacological inhibition of S1PR2 in human
lung ECs exacerbates MRSA-induced lung barrier permeability. This proposal seeks to elucidate the novel
mechanisms by which S1PR2 regulates vascular barrier function in response to MRSA-induced lung
injury. Specific Aim 1 will investigate the effects of MRSA on the expression and subcellular localization of
S1PR2 in lung ECs, as well as elucidate the role of S1PR2 in regulating endothelial injury caused by MRSA.
Using advanced assays to assess barrier function and vascular permeability, key processes in ARDS
pathophysiology, we will evaluate the effects of S1PR2 expression and activity on lung vascular function.
Additionally, we will examine the potential key role of the transcription factor KLF4 in mediating S1PR2 effects
through regulation of junctional proteins essential for endothelial barrier stability. Specific Aim 2 will determine
the role of S1PR2 in MRSA-induced ALI in vivo. We will compare the injury responses in S1PR2-deficient and
wild-type mice infected with live MRSA, evaluating multiple indices of lung injury. This aim will also utilize RNA
sequencing to identify genetic differences between these two strains, providing insights into S1PR2-dependent
pathways. Additionally, pharmacological inhibition of S1PR2 in C57BL/6 mice and endothelial specific S1PR2
knockdown will further clarify its role in vascular barrier regulation. This research will be conducted at the
University of Illinois Chicago in the Division of Pulmonary, Critical Care, Sleep and Allergy. By advancing our
understanding of endothelial barrier function in the context of MRSA-induced lung injury, this work will provide a
foundation for my K99/R00 award application and facilitate my transition to independent investigator status.

Public health relevance
PROJECT NARRATIVE Acute respiratory distress syndrome (ARDS) is a severe and often fatal form of respiratory failure that remains a significant challenge in intensive care units worldwide. Methicillin-resistant Staphylococcus aureus (MRSA) is a major infectious cause of ARDS, and preliminary data presented in this proposal demonstrates that the signaling receptor S1PR2 plays a critical role in maintaining the lung endothelial barrier during MRSA-induced acute lung injury. The proposed study aims to (i) investigate the mechanisms by which S1PR2 regulates MRSA- induced endothelial barrier dysfunction and injury in vitro and (ii) elucidate the role of S1PR2 in the regulation of MRSA-induced lung injury in vivo.